Nonhuman Primate Reagent Resource

Summary
The Nonhuman Primate Reagent Resource (NHPRR) has 21 years of continuous operation providing
specialized reagents to enable and enhance research with nonhuman primate (NHP) models of human
disease. This application describes our next five-year plan to develop and distribute these essential NHP-
tailored reagents.
NHPs serve a crucial role in translational research, providing animal models for exploring the
pathogenesis of infectious and noninfectious diseases, and for testing biological therapies and vaccines.
Antibodies and biological reagents that target specific immune cells and biomarkers can be essential
tools in determining disease mechanisms. Additionally, immunomodulators that can be studied in vivo
serve as proof-of-concept for new therapies. While these crucial research tools are available for small
animal and human studies, substantial gaps exist for validated NHP research reagents. To overcome
this scarcity, for the past 21 years, the NHPRR has fulfilled critical needs within the scientific community
by developing, manufacturing and distributing NHP-specific reagents for in vitro diagnostics and for in
vivo use. Utilization of this resource has grown dramatically since this program’s inception. During the
last five years (2015-2019), we fulfilled 2,821 reagent requests for 320 investigators and distributed
~2,500 grams of recombinant antibodies for administration to NHPs.
By continuously availing ourselves of future scientific advances and technological improvements in
antibody development, engineering, expression and vectoring, we will keep supporting the scientific
community utilizing NHP models across all scientific disciplines.

Public health relevance
Narrative The Nonhuman Primate Reagent Resource (NHPRR) develops, manufactures, and distributes research reagents for more than 21 years. These species-matched immunologic tools help investigators develop and utilize preclinical monkey models of human diseases–from infectious diseases to organ transplantation. This application describes the scientific and operational goals for our resource program's next cycle, using new reagent development methodologies and expanded community outreach plans to maximize the NHPRR's impact in nonhuman primate research.